Using Intradialytic Blood Pressure Slopes to Guide Ultrafiltration in Hemodialysis Patients

United States Veterans have disproportionately higher risk for end stage renal disease (ESRD) compared to
the general population. Veterans with ESRD on maintenance hemodialysis (HD) suffer from alarmingly high
mortality rates and hospitalizations mainly related to cardiovascular disease. Extracellular volume (ECV)
excess is a primary contributing factor to cardiovascular disease and the heightened mortality rate in HD
patients. Extracellular volume excess remains difficult to identify in clinical practice, and the standard
approach to fluid management in the clinical setting involves arbitrary trial and error attempts to remove fluid
without invoking hemodynamic instability such as intradialytic hypotension. Bioimpedance spectroscopy (BIS)
is a useful research tool for assessing ECV; however, it is not feasible in routine practice, and there is little data
on how its use affects intermediate and hard clinical outcomes. There is an unmet need for an approach to
guide ultrafiltration in clinical practice that addresses both reduction of ECV and other mortality outcomes as
well as minimization of intradialytic hypotension. The long-term goal of this study is to develop a more precise,
patient-specific fluid management approach to be tested in a large clinical trial aimed at reducing mortality in
Veterans on HD. The overall objective of this project is to utilize our novel, patient-specific ultrafiltration
algorithm as an intervention in a clinical trial using mortality risk factors as the primary outcomes. The central
hypothesis is that prescribing ultrafiltration prospectively based on an individual patient’s intradialytic blood
pressure slopes (IBPS) from recent treatments is superior to standard care at reducing ambulatory blood
pressure and ECV without increasing risk for intradialytic hypotension. Aim 1 will use an un-blinded, controlled
randomized clinical trial to demonstrate the effects of an IBPS-based ultrafiltration prescription compared to
standard clinical practice. Each month, updated ultrafiltration prescriptions for the IBPS group will be
determined based on the most recent treatment data. The primary outcome will be change in mean systolic
44-hour ambulatory blood pressure after 4 months. Other outcomes will include 1) change in post-HD
ECV/body weight using multifrequency bioimpedance spectroscopy, 2) change in post-HD total peripheral
resistance index using a non-invasive cardiac output monitor, and 3) between-group comparison of the
frequency of intradialytic hypotension and intradialytic symptoms. Aim 2 will involve a cross sectional analysis
of baseline data of subjects from Aim 1 in addition to consecutive enrollment of additional hypertensive HD
patients. In addition to Aim 1 measurements, subjects will undergo transthoracic echocardiograms on a non-
HD day to obtain measurements of left ventricular ejection fraction as a metric of systolic function, mitral inflow
and mitral annulus velocities as a metric of diastolic function, and left ventricular mass index. Mixed linear
models will be used to determine how these metrics independently influence the association between
ECV/body weight and IBPS. The strength of the association between IBPS and ECV/body weight will then be
determined within each tertile of the distributions of systolic and diastolic dysfunction. Finally, there will be an
assessment of how the echocardiogram based metrics influence the likelihood of intradialytic hypotension with
prospective follow up while controlling for ECV/body weight. If successful, this study will provide nephrologists
with an easily-implemented, individualized approach to fluid management in Veterans on HD that safely
reduces ECV excess and related mortality risk factors. Because no approach currently exits, this could
immediately change clinical practice of managing Veterans with ESRD. The long term impact will be the
opportunity to utilize the data generated to design a large, multi-center trial directly evaluating this
intervention’s effect on mortality in Veterans with ESRD on HD. The observed reduction in blood pressure can
be used to determine expected mortality, while the echocardiogram data can be used to determine phenotypes
of patients that may need to be considered for inclusion/exclusion criteria.

Public health relevance
Kidney failure has been recognized as one of the most costly chronic conditions among United States Veterans. Approximately 13,000 Veterans develop kidney failure each year, and most require hemodialysis initiation. Hemodialysis patients suffer significantly increased risk of death and hospitalizations, and excessive body fluid is a major cause of this. While empiric aggressive fluid removal during dialysis is one approach to limit fluid overload, this can cause dangerous decreases in blood pressure during dialysis that independently contribute to the high death rate. In this study, I aim to test a new strategy that prescribes fluid removal based on a patient’s recent blood pressure patterns during dialysis. This clinical trial will compare my strategy to standard care and assess the outcomes of overall blood pressure change between dialysis treatments in addition to the number of times the blood pressure becomes dangerously low during dialysis. Another aim is to determine how differences in the structure and function of the heart influence blood pressure during dialysis.